Understanding the role of emotion regulation flexibility in the association between daily stressors and emotional disorder symptoms in ethnic minority college students

PROJECT SUMMARY
Obtaining higher education is a pathway to upward social mobility, but this path is not equal for all students. For
instance, most first-generation (i.e., parents do not have a four-year degree) college students (CS) are likely to
identify as a racial or ethnic minority, come from low socio-economic backgrounds, and question whether they
belong and can succeed in academia. Indeed, ethnic minority CS are designated as at-risk, with the highest
dropout rates in postsecondary education. Ethnic minority CS also experience additional stressors in addition to
their first-generation status (e.g., experiences with racism and discrimination, educational hegemony,
acculturative stress, and financial concerns). These daily stressors are well-established risk factors for emotional
disorders (e.g., depression and anxiety disorders) and underscore the importance of one’s ability to regulate
emotions during stressful situations. However, the mental health of ethnic minority CS, particularly first-
generation CS, is vastly understudied, and a lack of representation perpetuates health disparities. Notably, a
critical limitation of previous emotion regulation (ER) work is taking a dichotomous approach that emphasizes
the adaptiveness or maladaptiveness of specific strategies, which may not be congruent with specific cultural
perspectives on emotions. Recently, various investigators proposed that successful ER is the ability to flexibly
implement and adjust a range of ER strategies given daily contextual demands (i.e., ER flexibility). Measuring
ER flexibility in real-time is critical to understanding the dynamic, contextual nature of ER. Given the impact of
daily stressors and emotional disorders on ethnic minority CS (e.g., poorer academic performance, relationship
instability, suicidal ideation), there is an urgent need to explore ER in this population. The primary objective of
this project is to understand the role of ER flexibility in the association between daily stressors and emotional
disorder symptoms in ethnic minority CS. ER flexibility will be assessed using ecological momentary
assessments (EMAs) administered three times daily for 14 days. Aim 1 will involve conducting three focus groups
with ethnic minority CS to collect qualitative and quantitative data on types of daily stressors experienced, beliefs
about ER and mental health, and ER goals. These focus groups will inform the design of the EMAs. Aims 2 and
3 will use EMA data from a novel sample of ethnic minority CS (those who did not participate in Aim 1). Aim 2
will examine how ER flexibility mediates the association between daily stressors and emotional disorder
symptoms. Aim 3 will explore how acculturation and first-generation CS status differences influence these
constructs. This project will contribute substantially to understanding the mental health needs of ethnically
diverse students and will create a foundation for future research to develop and test culturally-tailored
interventions, which may facilitate better mental health, address ongoing health disparities disproportionately
impacting ethnic minority CS, and increase their retention in academia and subsequent pathways out of poverty.

Public health relevance
PROJECT NARRATIVE Ethnic minority college students (CS), especially first-generation CS, are considered at-risk, with the highest dropout rates in postsecondary education. However, emotion regulation (ER) and the mental health of ethnic minority CS are vastly understudied, and a lack of representation perpetuates health disparities. This study will use ecological momentary assessments to (1) understand the role of ER flexibility in the association between daily stressors and emotional disorder symptoms, (2) develop a dynamic understanding of which deficits in the ER flexibility process confer risk to emotional disorders for ethnic minority CS, and (3) explore how first- generation CS status and levels of acculturation influence the selection and efficacy of ER strategies.